Training Grant in Vision Science

[unreadable] DESCRIPTION (provided by applicant): Twenty-one faculty of the Center for Visual Science (CVS) at the University of Rochester request renewal of support for a predoctoral and postdoctoral training program that emphasizes psychophysical, physiological, and computational approaches to vision. Training is interdisciplinary, drawing particularly on the unique technical and intellectual resources of the Center. It covers a broad range of basic and clinical problems in Vision, but emphasizes approaches that link visual performance to underlying neural mechanisms. We request each year support for seven predoctoral trainees, who will generally enter the program through Brain and Cognitive Science, Computer Science, Neuroscience, Biomedical Engineering, or the Institute of Optics. Students take core courses plus advanced seminars in visual science, augmented by courses from the department through which they entered the program. Concurrently with course work, students complete research projects in CVS preceptor labs. We request each year support for one postdoctoral fellow. Their training has a heavy emphasis on research. The training grant will be used especially to draw talented scientists from other areas into vision research. We are also requesting stipends for eight summer undergraduate research fellows to participate in an ongoing program that we have developed to introduce students to research in vision science and recruit students into graduate training in visual science. [unreadable] [unreadable] [unreadable]